The role of presynaptic C1QL3 in a hypothalamic arousal circuit

PROJECT SUMMARY:
Narcolepsy with cataplexy is a debilitating neurological disorder that results in sleep attacks during the day and
fragmented sleep at night. This condition is associated with the loss of hypocretin/orexin (HCRT/OX) neurons in
the lateral hypothalamic area (LHA), which are important regulators of sleep/wake behavior and arousal states.
Despite a broad array of work investigating HCRT/OX neuron function in physiology and behavior, comparatively
little is known about the molecular mechanisms underlying their synaptic structure and function. Based on the
results of our lab’s recent single cell RNA sequencing (scRNA-seq) analysis of the LHA, we propose that C1ql3,
encoding C1QL3, a previously described excitatory synapse organizing protein in other brain regions, may
likewise be an important element in excitatory synaptic transmission in HCRT/OX neurons, and help us shed
light on the molecular components of these important arousal-regulating synapses. To test this, I will confirm the
expression of C1ql3 and its gene product C1QL3 in HCRT/OX neurons, at both the mRNA and protein levels
(Aim 1). I will then conditionally knock out the C1ql3 gene in HCRT/OX neurons to determine the consequences
of its deletion on HCRT/OX synaptic structure and function (Aim 2), as well as its potential importance for
HCRT/OX neuron function in promoting arousal (Aim 3). This work will have several important outcomes,
including 1) identifying the role of a novel genetic marker in HCRT/OX neurons, 2) informing us of the importance
of C1QL3 in synaptic function and behavior relating to HCRT/OX neurons, and 3) provide me with training in
neuroscience techniques ranging from cellular and molecular to behavioral to enable me to become a more well-
rounded scientist and scientific communicator, as I pursue my goal of becoming an independent researcher.

Public health relevance
PROJECT NARRATIVE: Narcolepsy with cataplexy is a debilitating neurological disorder caused by the loss of hypocretin/orexin (HCRT/OX)-expressing neurons in the lateral hypothalamic area (LHA). While HCRT/OX neurons are critical regulators of sleep/wake states, little is known about the molecular underpinnings of their synaptic function. We hypothesize that the synaptic protein C1QL3, which we have identified as uniquely expressed in HCRT/OX neurons, is a critical component of the excitatory synapses that HCRT/OX neurons make at their targets throughout the brain, and is therefore is an important contributor to HCRT/OX-mediated regulation of the sleep/wake state.